Functional and Molecular Characterization of Epithelial Subtypes in Cervical Remodeling and Preterm Birth

Abstract
Preterm birth due to an ascending infection accounts for 25-40% of spontaneous preterm births. Disruptions in
the cervical epithelia that perturb its barrier and immune function is a risk factor for an ascending infection. Using
single cell transcriptomic and spatial approaches, epithelia subpopulations were identified in cervices from
nonpregnant mice and mice at gestation days 6, 12, 15, 18 and in labor. Unique to pregnancy was the expansion
of two populations of secretory goblet cells which produce a distinct mucus network and immune surveillance
factors. In the current proposal, we aim to identify the lineage of these secretory cells which express markers of
both squamous and columnar epithelia, and to define the progesterone and estrogen dependent gene regulatory
networks that regulate proliferation and differentiation of the two goblet subtypes. Using single cell datasets from
mice with epithelial barrier defects or mice with exposure to lipopolysaccharide to induce inflammation, we will
define perturbations in epithelial subtype functions that contribute to ascending infection risk. Finally, the
expression of olfactomedin 4, one immune surveillance factor upregulated in the goblet cells in pregnancy, will
be measured in cervico-vaginal fluid from women in each trimester of a term or preterm pregnancy to determine
its utility to monitor cervical epithelial cell health and risk of spontaneous preterm births.

Public health relevance
Narrative The cervical epithelium serves as the first line of defense during pregnancy to prevent ascending infections, a risk factor for preterm birth. Using single cell approaches, diverse subtypes of epithelial cells were identified in pregnancy that were unique in gene expression compared to nonpregnant. In the current study, the lineage and regulation of specialized secretory epithelia that are dominant in pregnancy will be identified and the impact on ascending infection risk determined when the secretory cells are perturbed. Insights from this work will identify biomarkers that predict risk of preterm birth and identify therapeutic clinical targets for prevention.